Targeted Delivery of Therapeutics by Engineered Commensal Microbes

PROJECT SUMMARY
The human body is a complex ecosystem supporting symbiotic relationships with thousands of microbial species
that are integral to the health and metabolism of their hosts. Exploration of these interactions has led to countless
insights into areas such as microbial metabolism and community dynamics. With this growing body of knowledge,
the opportunity now exists to capitalize on our increasingly sophisticated understanding of the human microbiota
by expanding our efforts beyond discovery and characterization, toward engineering. Commensal microbes are
already perfectly suited for safe and effective colonization of various physiological niches; what remains is to
take advantage of their incredible genomic plasticity and ability to function as robust biochemical factories. This
proposal aims to develop human commensal microbes as vehicles for delivery of therapeutic compounds to
targeted body sites, an endeavor that requires a multifaceted and synergistic engineering approach. Specifically,
we aim to engineer gut bacteria to produce and secrete targeted biological therapeutics such as antibody
fragments in situ, with the goal of addressing multiple critical issues in human health. Antibodies offer a less toxic
alternative to standard, non-specific treatments such as broad-spectrum antibiotics and chemotherapeutics. Due
to their exquisite specificity, antibodies are capable of selective action, such as inhibiting the growth of pathogenic
microbes without disturbing the native microbial community, and abolishing tumors without damaging healthy
tissue. The use of antibody therapeutics to efficiently treat a broad range of infection and disease, however, is
hindered by two major obstacles: (1) the cost to produce and administer them can be prohibitively expensive,
especially in the case of bacterial infectious disease and (2) standard intravenous delivery is inefficient for
gastrointestinal therapy while oral administration of therapeutic antibodies yields poor results. We will therefore
engineer a system in which therapeutic antibody fragments are produced by human commensal microbes
residing in the gut, providing continuous on-site delivery of targeted treatments for gastrointestinal infections and
disease. This approach addresses key issues in antibiotic specificity, toxicity, and resistance, while establishing
the groundwork for further development of biological therapeutics at lower cost and greater convenience.

Public health relevance
PROJECT NARRATIVE Commensal microbes are already perfectly suited for safe and effective colonization of various physiological niches; what remains is to take advantage of their incredible genomic plasticity and ability to function as robust biochemical factories. This project will develop human commensal microbes as vehicles for delivery of therapeutic compounds directly to the site of disease in the gastrointestinal tract. To achieve this, we will engineer gut bacteria to produce and secrete targeted biological therapeutics such as antibody fragments in situ, with the goal of addressing critical issues in human health, including antibiotic resistance, toxicity, and rapid response to emerging threats.